Office of Translational Resources

Projects supported in FY25 focused on: CD-25 Immunotoxin for mesothelioma; PIT using EGFR combined with anti-CD-25; CAR-T therapy targeting glypican 2 (GPC2) in neuroblastoma; Genetic engineering of myeloid cells (GEMys) to reduce metastasis; Aerosolized drug delivery for lung cancer; HIV vaccine; Zika virus as a potential therapeutic strategy for pediatric and adult cancers; Inhibitors for fusion-positive rhabdomyosarcoma; ADCs targeting FGFR4; Intratumoral injection of repurposed vaccines in solid tumors; EGFRvIII targeted therapies